Social Processes Underlying Co-Occurring ADHD and Anxiety Across the Lifespan

ABSTRACT/PROJECT SUMMARY
Anxiety is one of the most common and debilitating comorbidities with ADHD, affecting 57% of youth and 84%
of adults, with particularly high rates in girls and women. Despite its widespread prevalence, this co-occurrence
is often overlooked and poorly understood, contributing to worse mental health outcomes and greater economic
costs than either condition alone. Social processes (i.e., social cognitions and relationships) appear to contribute
to the emergence of anxiety in youth with ADHD, but extant work has most often relied on mother-reports in
community samples, lacking a multi-informant perspective and consideration of how ADHD and anxiety co-occur
across development or in clinical populations. These gaps hinder our ability to provide effective, timely
interventions, leaving those at highest risk—especially girls and women—without the necessary support. There
is also a notable lack of research on girls and women with ADHD and potential sex differences, despite growing
identification of ADHD in girls and women, many of whom are identified with anxiety prior to diagnosis of ADHD.
Aligned with Goal 2 of the NIH Strategic Plan (Examine Mental Illness Trajectories Across the Lifespan), this
project will address these gaps using three existing datasets with large samples of girls and women. Aim 1 will
use ongoing clinical cohort data from a specialized lifespan ADHD clinic to identify developmentally relevant
social processes in the co-occurrence of ADHD and anxiety in children and adults, utilizing one of the most well-
characterized and ecologically valid samples of girls and women with ADHD to date. Aim 2 will use data from
two completed studies and one ongoing study to examine electroencephalography (EEG) measures of social
processing as markers of ADHD and anxiety, as well as sex differences, in adolescents—a critical period for
anxiety onset and heightened social sensitivity, particularly in girls. Findings will provide developmentally and
sex-specific insights into altered social processing as a mechanism for co-occurring ADHD and anxiety, along
with neural biomarkers during a critical risk period. With mentorship from experts in lifespan ADHD and sex
differences (Babinski), EEG methods for assessing anxiety risk (Pérez-Edgar), measurement-based ADHD care
in clinical settings (Waschbusch), and translational analytics/bioinformatics in clinical data (Tuan), this project is
designed with an integrated training plan to provide the applicant with real-world clinical research experience,
focusing on advanced data analytics to how altered social processing contributes to co-occurring ADHD and
anxiety across the lifespan, alongside innovative EEG methods to identify neural markers of these processes.
The exceptional mentorship team, coupled with the resources and infrastructure at Penn State College of
Medicine, offers the optimal environment to support the applicant’s training goals, foster professional
development, and promote growth as an independent ADHD researcher focused on identifying developmentally
and sex-specific comorbidity risks in ecologically valid populations across development.

Public health relevance
PROJECT NARRATIVE Co-occurring ADHD and anxiety is often overlooked and poorly understood, leading to higher suicide rates, poorer prognoses, and greater lifetime economic burdens than in either condition alone. The proposed project will capitalize on real-world data from a lifespan ADHD clinic to examine developmentally-relevant social processes that contribute to co-occurring ADHD and anxiety across the lifespan, as well as innovative neurophysiological methods to identify neural markers of these processes during a critical developmental period. Findings will provide novel insights into developmentally sensitive and sex-specific mechanisms underlying co- occurring ADHD and anxiety in a highly ecologically valid sample, supporting the refinement of prevention and treatment strategies for those most at risk.